Project 1 Viral Genomics: surveillance, epidemiology, host response, and viral immunogenicity

Project Summary/Abstract
Clinical rebound following treatment with nirmatrelvir-ritonar has been reported. The incidence,
virology, and clinical consequence of this syndrome are not clear. The investigators will conduct
a study of nirmatrelvir-ritonavir rebound with the following objectives:
Objective 1: Determine the incidence and risk factors for symptomatic and asymptomatic
virologic rebound after nirmatrelvir-ritonavir therapy
Objective 2: Determine the duration and magnitude of virologic rebound and contagiousness of
symptomatic and asymptomatic rebound after nirmatrelvir-ritonavir therapy
Objective 3: Estimate the incidence of treatment-emergent drug resistance after rebound
Objective 4: Describe clinical outcomes with and without virologic rebound following
nirmatrelvir-ritonavir therapy in a real-world setting
By carrying out these objectives, the investigators will define the incidence of rebound after
nirmatrelvir-ritonavir and characterize the associated syndrome using quantitative measurement
of viral load, viral culture, and whole virus genome sequencing.

Public health relevance
Project Narrative Rebound of clinical symptoms following administration of nirmatrelvir-ritonavir has recently been reported. The incidence, virology, and clinical consequence of this syndrome are not clear. The investigators will characterize rebound after nirmatrelvir-ritonavir using quantitative measurement of viral load, viral culture, and whole virus genome sequencing in a prospectively enrolled cohort of patients.